The California Abundant Birth Project Evaluation: Advancing Birth Equity through Guaranteed Income for Pregnant People

Project Summary/Abstract
Pregnancy is a critical period of development: stress during pregnancy can lead to adverse birth
and long-term health outcomes, as well as compromise infant development. In the United
States, racial inequities in pregnancy and birth outcomes are stark and persistent, signaling the
need for novel interventions that address the social determinants of health. The California
Abundant Birth Project (CA-ABP) is a guaranteed income program for pregnant populations at
elevated risk of preterm birth in five California counties (San Francisco, Alameda, Contra Costa,
Riverside, and Los Angeles), funded by the State of California, municipal governments, and
philanthropic funding. The CA-ABP program will provide 12-18 months of unconditional, monthly
income supplements during pregnancy and postpartum to randomly selected participants, with
the goal of curbing financial stress and promoting healthy pregnancy outcomes.
The goal of the CA-ABP Evaluation is to use a rigorous, mixed-methods, community-based
participatory research approach to determine whether providing guaranteed income to Black
pregnant people can advance perinatal health equity through the reduction of adverse
pregnancy outcomes and stress, and improvements in maternal mental health and infant
development. The proposed project significantly expands the scope of the impact evaluation of
CA-ABP by adding three additional survey data collection timepoints (6-weeks postpartum, 6-
months postpartum, and 12-months postpartum) and medical records abstraction. The study
focuses on the subset of Black-identified participants to determine the impact of income
supplementation during pregnancy on: (1) perinatal health, as measured by composite
measures of adverse pregnancy outcomes (preterm birth, low birth weight, small-for-gestational
age, gestational hypertension, preeclampsia, and gestational diabetes); (2) stress and perinatal
mental health (depression and anxiety); and (3) infant development.
Eliminating maternal and infant health inequities requires a paradigm shift in research,
interventions, and policies that emphasize upstream solutions rather than placing responsibility
on affected communities. Understanding the impact of CA-ABP on perinatal health and infant
development will provide the foundation for interventions that address stress and economic
inequality caused by structural racism. Conducting the evaluation in partnership with the
organizations implementing ABP provides a direct pathway to move forward the results for
policy change and sustainability.

Public health relevance
Project Narrative This project presents the first opportunity to evaluate the impact of unconditional income supplementation on pregnancy outcomes and infant development among Black birthing people in the United States, a population that experiences stark disparities and that has not seen improvements in perinatal health, despite a host of clinical intervention approaches. Evidence from non-U.S. settings suggests the potential for improvements in birth outcomes and perinatal mental health because of unconditional income supplementation, yet these settings have implemented smaller income supplements in the face of different economic contexts, approaches to health insurance, and legacies of colonialization and ongoing structural racism. The results of this study can support the advancement of income supplementation as health equity strategy to improve pregnancy outcomes and infant development.